Imaging genetics of laryngeal dystonia

PROJECT SUMMARY / ABSTRACT
Laryngeal dystonia (LD), or spasmodic dysphonia, is isolated focal dystonia characterized by selective
impairment of speech production due to involuntary spasms in the laryngeal muscles. Despite well-
characterized clinical features of LD, its clinical management remains challenging due, in part, to the absence
of objective measures (biomarkers) for early detection and differential diagnosis. This results in diagnostic
inaccuracies, which have a negative impact on the patient’s quality of life and healthcare costs. Importantly,
delayed diagnosis leads to deferred treatment. The objective of this application is to conduct a series of studies
that combine advanced machine-learning with neuroimaging and genetics to (1) identify the neural markers
that accurately differentiate LD between its clinical phenotypes (adductor vs. abductor), genotypes (sporadic
vs. familial), and comorbid disorders (voice tremor and muscle tension dysphonia); (2) determine the early
predictive neural markers of LD development in at-risk individuals, and (3) validate associated LD gene
mutations. Supported by our preliminary data, our central hypothesis is that brain abnormalities are shaped, in
part, by underlying genetic factors and exhibit LD form-characteristic features, which can be used as
differential diagnostic and early predictive biomarkers of this disorder. This research is innovative both
conceptually and methodologically because it uses a cross-disciplinary approach to focus on the neural
pathophysiology and genetic susceptibility factors for LD diagnostic and predictive biomarker discovery. The
proposed research is significant because it will directly contribute to closing the critically existing gap in the
clinical management of LD. Identification of LD neural and genetic markers is expected to have a positive
translational impact by establishing enhanced criteria for accurate differential diagnosis and screening of
persons at risk. In short, the successful completion of these studies will open new horizons for the clinical
management of LD patients.

Public health relevance
PROJECT NARRATIVE The proposed research aims to identify the neural and genetic markers of laryngeal dystonia (LD), which is a task-specific form of isolated focal dystonia characterized by involuntary spasms in the laryngeal muscles during speaking. The proposed research is relevant to public health because it is expected to have an ultimate positive translational impact on establishing the enhanced criteria for improved clinical management of LD, including its early detection and accurate diagnosis. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge that will help reduce the burden of human disability.